PRE-DETERMINE: Advancing Sudden Arrhythmic Death Prediction in Coronary Artery Disease in the Absence of Severe Systolic Dysfunction

Sudden and/or arrhythmic death (SAD), which typically results from lethal ventricular arrhythmias (ventricular
tachycardia and ventricular fibrillation, VT/VF) in the setting of coronary heart disease (CHD), afflicts an
estimated 310,000 persons annually in the United States. Reductions in SAD have continued to lag those
observed for other coronary heart disease (CHD) outcomes despite advances in resuscitation therapies and
the use of implantable cardioverter-defibrillators (ICDs). Current approaches to SAD prevention remain
centered on placing ICDs in patients with left ventricular ejection fraction (LVEF) <30-35% – even though the
majority of SAD occurs in the setting of LVEF >30-35%. In effect, the proportionately larger segment of the
at-risk population has been understudied and thus undertreated. Despite this unmet need, there remain very
few, if any, prospective studies examining SAD risk prediction in individuals with CHD and LVEF >30-35% over
a long enough time horizon where ICD therapy might be cost-effective. For this very reason, the PRE-
DETERMINE Cohort Study was intentionally designed to address this scientific gap and prospectively
study clinically relevant approaches to SAD risk prediction in CHD patients with LVEF >30-35%. In this
application, we propose to leverage the originally NHLBI-funded base cohort resource to continue adjudication
of accruing SAD and VT/VF events, in addition to competing causes of death, to attain 10+ years of endpoint
adjudication to enable the development and validation of multi-marker SAD risk prediction models based on
combinations of multi-dimensional clinical, ECG, imaging, biomarker, and genetic data generated in this unique
multicenter cohort of 5761 CHD patients. We will also leverage the base cohort to interrogate novel fatty acid
derived eicosanoids and putative arrhythmia modulating proteomic analytes in relation to risk for SAD and
competing causes of mortality in patients with CHD. Novel methods of competing risk analyses will be used to
integrate absolute and proportional SAD risk into SAD risk prediction models and to elucidate separate
associations between SAD vs. non-SAD causes of death. Machine learning approaches will be applied to
uncover inter-relations and latent features from multi-modality data not easily detected by conventional models.
An overarching goal of our work is to accurately identify those individual subsets of the broader population who
have sufficiently high absolute and proportional risk for SAD that they warrant inclusion in randomized trials of
primary prevention ICD therapy. The aims of the current proposal also offer new opportunities to identify
potential mechanistic pathways underlying the genesis of lethal ventricular arrhythmias that could serve as
novel targets for SAD prevention – extending beyond ICD placement – in patients with CHD and possibly even
in the general population wherein CHD underlies most SAD events. The continuation and expansion of the
PRE-DETERMINE study will provide the scientific field with a one-of-a kind resource for investigators and
trainees collaborating toward the common goal of reducing the burden of SAD.

Public health relevance
There are an estimated 310,000 sudden deaths from heart disease in the United States each year. These deaths are the result of a fatal heart rhythm disturbance most often occurring in patients with underlying coronary artery disease who do not have evidence for severe heart damage. The present study aims to more accurately identify people who are at risk for developing life-threatening heart rhythm disturbances using blood tests and electrocardiograms (ECGs) so that we can intervene and prevent these sudden deaths.